Development and Pilot Testing of an Adaptive Intervention to Prevent Weight Regain Following Weight Loss in Adults with Overweight and Obesity

PROJECT SUMMARY/ABSTRACT
This is an application for a K01 award for Dr. Tanya Halliday, an Assistant Professor in the Department of Health
& Kinesiology in the College of Health at the University of Utah. Dr. Halliday is establishing herself as an
emerging leader in obesity research, specifically in developing efficacious weight loss maintenance interventions.
This K01 award will provide Dr. Halliday the support necessary to accomplish the following goals: 1) Strengthen
skills in qualitative research and mixed methods approaches; 2) Develop expertise in complex clinical trial
design, particularly adaptive interventions and SMART designs with longitudinal follow-up; and 3) Develop
advanced research leadership and management skills.
To achieve these goals, Dr. Halliday has assembled a mentoring team comprised of a two Co-Primary Mentors.
Dr. Molly Conroy, a physician-scientist experienced in performing large-scale health behavior RCTs, including
studies of weight loss maintenance, and Dr. Julie Fritz, clinical and translational scientist with expertise in utilizing
adaptive interventions, a type of study design which will be developed and tested to prevent weight regain in the
proposed K01, and SMART designs. Dr. Halliday will also be mentored in qualitative research methods and
analysis by Dr. Susan Zickmund, with Dr. Jincheng Shen serving as an advisor for biostatics for adaptive design
trials.
The lack of successful long-term weight loss interventions is the greatest challenge for obesity management.
Based on recent evidence, and her own preliminary data, Dr. Halliday’s central hypothesis is that an adaptive
intervention involving individually tailored re-engagement with professional support will be feasible and able to
prevent weight regain following intentional weight loss. She will test this hypothesis by developing and pilot
testing and 6-month adaptive re-engagement intervention in adults whom have recently lost a significant (≥7%)
amount of weight with lifestyle (diet/exercise) interventions. By pursuing the following specific aims, the applicant
will test her hypothesis and gather data for a clinical trial to 1) Qualitatively explore weight regain triggers for
weight-reduced adults as well as preferred aspects of an evidence-based adaptive re-engagement intervention;
2) Develop an adaptive intervention to re-engage patients at times they are at risk of weight-regain; and 3)
Determine the feasibility of an adaptive re-engagement intervention to prevent weight regain.
The proposed research is significant because weight loss interventions are unsuccessful long-term and new
approaches to prevent weight regain are needed. The proposed research is innovative because adaptive re-
engagement trials have not been evaluated as a weight loss maintenance approach; adaptive interventions are
typically not developed with rigorous preliminary work like that proposed in this project; and outcome measures
will be evaluated after 6-months of follow-up to determine the longitudinal feasibility of the adaptive intervention
to prevent weight regain.

Public health relevance
PROJECT NARRATIVE The high prevalence of weight regain following intentional weight loss is the most significant and unresolved challenge in obesity medicine. This project will utilize qualitative data to design and then pilot, an adaptive intervention to prevent weight regain following weight loss in adults with obesity. This line of research will ultimately improve the health and clinical care of adults with obesity.